NTP INFORMATION SYSTEMS SUPPORT

The goal of this contract is to provide support of National Toxicology Program (NTP) hazard identification activities targeted toward the prevention of diseases or adverse effects caused by environmental exposure to chemical or physical agents. The purpose of this contract is to provide computer and central files support services to the NTP. Central Files support includes the maintenance of National Toxicology Program study and study-related files and extending the current filing system as chemical studies are initiated as well as modifying or developing improved procedures for records management and data management. The Central Files contractor serves as an NTP staff resource for information on NTP chemicals. The Contractor also responds to public information requests for NTP testing, results and status information and plays a major role in the management of the NTP databases and the NTP Web Server. The contractor is responsible for files relating to study design, performance, and reporting of NTP studies and maintains relevant material relating to chemical-specific studies conducted or sponsored by the NTP which include toxicology, carcinogenesis, neurobehavioral, chemical disposition, teratology, and reproductive, genetic toxicity and related in-house studies. The NTP Central Files are functionally divided into chemical studies files, contract activities files and a discipline supporting all NTP analytical chemistry functions. NTP Information Computing Systems support includes managing the NTP Internet and Intranet, various databases and applications. Databases include Chemtrack, which is the NTP Information tracking system for nominations, studies, contracts and test articles, GT which is used to maintain data on the Genetic Toxicology studies, and SharePoint which contains NTP Central Files electronic files. Management of the NTP Central Files and Information Systems involves maintaining the current electronic files as well as developing and maintaining database systems for tracking these files. This also includes the development of new database tracking &retrieval systems as needed as well as maintenance of existing computer. This task includes the development of web-based methods of retrieval and display.